Diabetes Models Phenotyping

ABSTRACT: Diabetes Models Phenotyping Core
The Diabetes Models Phenotyping Core of the Washington University Diabetes Research Center (DRC) has a
long-term goal of enhancing diabetes-related research at Washington University through the use of
sophisticated services and technologies likely to contribute to discoveries that can be translated to novel
treatments for diabetes and its complications. The three objectives of the Core are: 1) To provide phenotyping
services to DRC members in order to facilitate NIH-funded diabetes/metabolism-related research and enhance
the cost-effectiveness of that research; 2) To train DRC investigators in the maintenance and manipulation of
mouse colonies relevant to diabetes and metabolic research; and 3) To develop new research capabilities to
enhance the ability of DRC members to perform diabetes and metabolic research. The Core fulfills an
important need in the diabetes research community with 52 DRC investigators utilizing services during the past
funding period. Over this time frame, the Core provided extensive support that included more than 7,000
biochemical assays of serum, more than 4,400 determinations of mouse body composition, and more than
1,000 indirect calorimetry assessments in mice, to mention the services in greatest demand. Evidence of
considerable Core evolution include: elimination of some services, institution of better defined quality control,
expanded training to include rigorous approaches to normalizing energy balance and other issues (all in
response to criticisms at the time of the last competitive renewal), addition of new instrumentation, upgrades to
existing instrumentation, increased physical size of the Core, and improved operational flow. Over this current
project period, Diabetes Models Phenotyping Core support helped users contribute a series of important
scholarly advances with substantial potential for translation to improved care for people with diabetes.

Public health relevance
NARRATIVE: Diabetes Models Phenotyping Core Diabetes and its related metabolic disorders are serious public health problems that lead to death and disability. Diabetes can be mimicked in animal models, and the study of these models can lead to new treatments with the potential to decrease the suffering from diabetes and its complications. The Diabetes Models Phenotyping Core facility has a goal of supporting scientists who study animal models of diabetes so that novel approaches can be identified to improve the health of people with diabetes.